Speech Intervention via Telepractice for Children with Repaired Cleft Palate : Randomized Controlled Trial and Assessment of Speech Production and Perception Skills

PROJECT SUMMARY/ABSTRACT
Although the Individuals with Disabilities Education Act (IDEA) ensures that all children with disabilities
are provided with appropriate public education, there is an increasing inequity in the provision of speech-
language services across the U.S. due to the critical shortage of speech-language pathologists (SLPs) in public
school settings. Telepractice is one way to mitigate the shortage issue. Currently available telepractice studies
have been conducted with small sample sizes and varying methodological rigor. In particular, to date no
treatment efficacy studies via telepractice have been conducted on children with a history of cleft palate (CP).
Children with repaired CP often develop compensatory articulation patterns which are not common in children
with speech disorders. It is imperative to identify whether telepractice is efficacious for children with repaired CP
to treat compensatory articulation. In evaluation of compensatory articulation errors, two major limitations exist
in the current literature. First, these errors are mainly examined based on the listener's auditory-perceptual
judgement without instrumental analysis; second, how speech perception plays a role in production of
compensatory articulation has not been fully investigated although ample evidence suggests interplay between
perception and production skills.
As a Phase I randomized controlled trial (RCT), this proposal responds to the NIDCR Behavioral Social
Intervention Clinical Trial Planning & Implementation Cooperative Agreement (UG3/UH3). This proposal fits with
NIDCR's Strategic Plan in that it aims to develop and test an effective behavioral intervention for children with
oral and craniofacial disorders. Our aim during the UG3 one-year planning period is to (1) finalize the intervention
protocols, (2) develop the Manual of Operations, (3) develop custom software for the data management system,
and (4) stimuli and software development for the speech perception experiment in order to complete an unbiased
RCT design for the UH3 phase. Our primary aims during the UH3 phase are (Aim 1) to establish the efficacy of
telepractice speech intervention for children with repaired CP, and (Aim 2) to quantitatively define compensatory
articulation errors using instrumentation analyses, and (Aim 3) to determine speech perception deficits in children
with CP. This research will be clinically significant because Aim 1 will assist clinicians to make evidence-based
decisions to adopt a telepractice service delivery model to treat children with repaired CP. Aims 2-3 will provide
important clinical rationales to evaluate speech production using instrumental analyses and to identify speech
perception deficits when clinicians treat children with CP. The importance of this study is highlighted by the
current COVID-19 pandemic. The associated social-distancing restrictions have been imposed upon school
teachers and SLPs to adopt telepractice while continuing to provide educational and therapeutic services. Thus,
the results of the proposed study will meet an increasing demand for telepractice efficacy studies for children
with speech disorders.

Public health relevance
Project Narratives A substantially large number of children who need speech and language services are currently underserved in the US. Telepractice, the provision of speech-language services using communication technologies, has been considered as a way to enhance provision of speech-language services. The proposed study will develop a robust clinical intervention program, and test the efficacy of speech intervention via telepractice for children with a history of cleft palate using a randomized controlled trial design.